Washington Heights Initiative Community-based Comparative Effectiveness Research

DESCRIPTION (provided by applicant): The overall goal of this project is to advance comparative effectiveness research designed to improve hypertension care delivery and population outcomes by building on an existing institution-focused data infrastructure to create a robust community-focused data infrastructure that will support the kinds of innovative studies needed to effectively tackle seemingly intractable public health problems. This will be done through the Washington Heights/Inwood Informatics Infrastructure for Community-Centered Comparative Effectiveness Research (WICER). WICER contains a research data warehouse that integrates patient-level data, including clinical data from multiple facilities, settings and sites of care, with person-level self-reported information and will map the linked data to variables that support prospective comparative effectiveness research studies. It also will provide tools to support researchers in accessing this infrastructure to perform retrospective analyses and recruit patients for research studies. We will then demonstrate how this infrastructure can support three comparative effectiveness studies on hypertension. These three studies will relate to the diagnosis, treatment and management of hypertension in patients. Our project will augment an existing data infrastructure, enhance access through state of the science tools, and achieve greater integration of both the data and the health care organizations that contribute to it. This in turn will enable us to conduct both the proposed and subsequent comparative effectiveness studies generating evidence to inform effective diagnosis and treatment of hypertension, and ultimately a wider range of related community health problems. PUBLIC HEALTH RELEVANCE: This research has the potential to improve the evidence base for treatment hypertension and other clinical conditions for a medically underserved, minority, low income, immigrant patient population. Currently, the evidence base for care delivery is not strong for this population, resulting in disparities in health care and outcomes. Insights gained through working with this specific population will then be generalizable to other such communities and populations.

Public health relevance
Project Narrative This research has the potential to improve the evidence base for treatment hypertension and other clinical conditions for a medically underserved, minority, low income, immigrant patient population. Currently, the evidence base for care delivery is not strong for this population, resulting in disparities in health care and outcomes. Insights gained through working with this specific population will then be generalizable to other such communities and populations.